Administrative Core

ADMINISTRATIVE CORE (AC)
PROJECT/SUMMARY ABSTRACT
The overall goals of the Administrative Core (AC) are to provide organizational, administrative, fiscal,
communication, and reporting support to each Project and Core within the Program Project (P01), entitled
"Atrial Fibrillation Post-GWAS: Mechanisms to Treatment." Our overall theme is to translate AF genomic
discoveries back to the bedside, focusing on genes to mechanisms, genes to drugs, and interactions of
genes with metabolism and environment. In conjunction with the Executive Committee (EC), consisting of
the Program Director, Project Leads and Core Directors, the AC will promote collaboration and synergy for
all P01 components; centrally monitor and evaluate their performance; and facilitate interactions with the
Internal Advisory Board (IAB) and External Advisory Board (EAB). The AC will promote integration,
efficiency of resource use, and organizational and administrative support. The AC will be essential in
coordinating all communications and reviewing all activities among all Projects and all Cores. Importantly,
the AC will work closely with the EC and Cores to coordinate generation, maintenance, and experimental
use of human cell and mouse models that will optimize experimental design, use of these resources, and
integration of all Projects and Cores to efficiently accelerate the Program towards completion of its goals.
The aims of the Core are to: 1) Promote collaboration and integration of the Program by providing
organizational and administrative support; 2) Facilitate scientific exchange, dissemination of results, and
communications; 3) Evaluate and promote research progress; 4) Provide managerial and fiscal grant
management; and 5) Ensure and monitor best practices, resource utilization and coordination. The Core will
promote best practices for rigor and responsibility, animal and human subjects research, responsible
conduct of research, and mentoring and coaching of early stage investigators. The AC will monitor
Projects and Scientific Cores and assure that sex as a biological variable has been addressed. In
summary, the Administrative Core will function to unify and coordinate activities amongst the Program
Project participants. It will facilitate organizational and administrative management of the Program,
provide centralized access and coordination for cell and mouse experiment planning, and enhance
significance, scope and scale of the projects. The services of this core do not replicate efforts of
established cores at Cleveland Clinic, making this core uniquely designed to support P01 investigators.